Agilent 6495 Triple Quadrupole Mass Spectrometer for Targeted Quantitation

Project Summary/Abstract
Stanford is in dire need of a modern triple quadrupole mass spectrometer to serve the needs of
our campus community of biomedical researchers. The proposed Agilent 6495C LC/MS system
will replace an 11-year-old workhorse instrument at Stanford University Mass Spectrometry, the
campus-wide shared resource. This premier bioanalytical platform will bring both new
capabilities and greater bandwidth to positively impact the goals of NIH-funded researchers. The
instrument performance requirements for modern research have long eclipsed the usefulness of
our existing instruments in terms of sensitivity and linearity as well as capacity for high-demand
applications in NIH-funded biomedical research projects. Our users require the capability to
observe and quantify a greater number and diversity of analytes simply not obtainable on
existing platforms, and to do so at larger sample scale to address their growing biomedical
research needs. The Agilent 6495C LC/MS will support numerous existing projects with current
NIH funding which are either unable to proceed due to lack of capability on campus or greatly
delayed due to lack of bandwidth with sufficient performance to meet their application needs.
Stanford University Mass Spectrometry has all of the technical expertise, physical infrastructure,
and administrative processes already in place and ready to be unlocked upon instrument
installation. The addition of this instrument would immediately accelerate numerous key
research areas, including heart disease, cancer, neurodegeneration, aging, arthritis, diabetes,
and sensory impairment diseases.

Public health relevance
Project Narrative This proposal requests funding for a modern triple quadrupole mass spectrometer system to be placed in Stanford University’s Mass Spectrometry core resource laboratory. The Agilent 6495C LC/MS system will increase capacity and provide significantly greater sensitivity over existing capabilities on campus. It will positively impact NIH researchers’ ability to investigate more diverse and biologically relevant groups of targeted peptides, small molecules and metabolites in a single experiment without compromising sensitivity, quantitative accuracy, or linearity as in our current platforms. This leap forward in capability will support a broad range of NIH-funded research areas, including heart disease, cancer, neurodegeneration, aging, arthritis, diabetes, and sensory impairment diseases.